CSHL 2023 Eukaryotic DNA Replication and Genome Maintenance Conference

2023 CSHL CONFERENCE ON EUKARYOTIC DNA REPLICATION & GENOME MAINTENANCE
PROJECT SUMMARY/ABSTRACT
This conference will be the 19th biennial meeting on Eukaryotic DNA Replication and Genome
Maintenance and follows the highly successful meetings that have been held at Cold Spring Harbor every other
year since September 1987. It is the only regularly occurring meeting that is exclusively focused on eukaryotic
DNA replication. Because of this focus, the meeting has played a major role in the rapid growth in our
understanding of the eukaryotic DNA replication process and how it is integrated into the cell division cycle. This
year’s conference will be devoted to fundamental research topics related to chromosome duplication, structure
and function, and will include important areas of biological research in the areas of cell cycle and growth control,
genomic amplification, and the response of the replication apparatus to DNA damage. As the field has moved
forward over the past decade, we have placed an increased emphasis on the central role of DNA replication in
the DNA damage and replication stress response, and strategies used by cells to minimize threats to genomic
integrity arising from DNA replication. The rapid convergence of the DNA replication and DNA damage response
fields makes this a timely meeting. The format of the meeting will ensure that recent results are communicated
and discussed face-to-face, which will enhance progress and collaboration. The participation of young
investigators, minority, and women scientists is strongly encouraged.
The 2023 meeting will include a diverse array of topics, systems, and approaches including studies of
chromosomal replication and gene amplification in organisms as diverse as bacteria, yeast, Drosophila, Xenopus
and mammalian cells. Sessions will cover (1) Replication Origin Control in the Cell Cycle; (2) Developmental
Control of DNA Replication and Replication Timing; (3) Chromatin and Genome/Nuclear Architecture; (4)
Replication Fork Stalling, Stabilization and Checkpoint Activation; (5) Replication Initiation Factors and Origin
Activation; (6) Replication-Coupled Genome Instability, Cancer and Disease (7) Causes and Consequences of
Replication Stress; (8) Fork Progression and Termination. Uncontrolled DNA replication is a hallmark of tumors
and errors in DNA replication lead to genomic instability, while the process of chromosome replication is a major
target for chemo- and radiotherapy. The relevance of this meeting to cancer research, and ultimately to improved
therapies, cannot be overemphasized.
Replication of DNA is a fundamental process in all (eukaryotic) life. This meeting will focus on
understanding the mechanism by which this process occurs, and how DNA replication contributes to genome
stability, maintenance of the epigenetic state of a cell and how misregulation of this process contributes to
diseases, most notably, cancer. The intellectual merits of this conference include the opportunity for leading
investigators at all stages of their scientific careers to share and discuss their latest results and concepts. The
informal peer review in oral and poster sessions is invaluable in providing rapid feedback that will fruitfully steer
and accelerate future research. This conference also provides ample opportunity for learning and for building
collaborations. We do not plan parallel sessions within the schedule so that all attendees share a common
experience, while the secluded venue maximizes the likelihood of productive scientific exchange.
Large, established conferences generally can have significant impact, and this Cold Spring meeting has
undoubtedly driven forward research in DNA replication. Unique aspects of this conference that have particularly
broad impact are the active participation of younger scientists who will particularly benefit from the opportunity
to present their latest ideas. The conference archive (Leading strand video archive accessible by the internet)
allows participants to share aspects of the conference with their colleagues who were unable to attend while
protecting the right of the presenting authors to present unpublished research.

Public health relevance
2023 CSHL CONFERENCE ON EUKARYOTIC DNA REPLICATION & GENOME MAINTENANCE LAY STATEMENT The duplication of the genetic material (DNA) is a process central to all unicellular and multicellular organisms. In higher plants and animals, the genetic material is packaged together with specialized proteins in structures called chromosomes that are themselves packed within the cell nucleus. How these chromosomes are duplicated, and how the DNA they contain is replicated, to allow faithful copies to be made from generation to generation, is a central question in biology. The entirety of the DNA of an organism (its “genome”) has to be copied with minimal errors every time the cell divides. This involves multiple “proof-reading” and “error-correction” mechanisms that operate at the molecular level to ensure excellent copying fidelity. When cells begin to divide uncontrollably during the development of cancer, errors tend to accumulate which themselves then contribute to how the disease progresses. The centrality and importance of this process, and its relevance to the development of cancer in particular, has led a large but diverse group of scientists towards the study of DNA replication in numerous systems. The aim of the conference on Eukaryotic DNA Replication & Genome Maintenance is to provide a forum to bring together the diverse group of scientists working in different areas of this field. The conference will be an open international meeting devoted to the most recent advances in the rapidly evolving field of eukaryotic DNA replication and the maintenance of genome integrity. Oral presentations will consist of a combination of invited presentations and selected presentations from submitted abstracts. This ensures the participation of junior and senior leaders in the field and the presentation of the most exciting results emerging at the time of the meeting. The oral presentations will be complemented by poster presentations in two poster sessions, also selected from submitted abstracts.